Control of the Survival Pathways in TH17 Cells

Project Summary
Despite their function in host defense, TH17 cells play a pathogenic role in many inflammatory
and autoimmune diseases. Although several biologics and inhibitors are promising, there are
currently only limited treatments for TH17-mediated diseases. Activating the death pathways in
TH17 cells, which may control the diseases at the root, remains elusive and represents a critical
gap in our knowledge. TH17 cells, due to the expression of high levels of the anti-apoptotic
protein FLIP, are resistant to activation-induced cell death (AICD). In addition, TH17 cells are
refractory to the broadly used steroid treatments in many inflammatory disorders. Therefore, we
explored non-steroid pathways that control TH17 cell function and survival. TH17-promoting
cytokines, including IL-6, IL-23, and IL-21, activate STAT3 and play essential roles in the
differentiation, function, and maintenance of TH17 cells. Recently, we found that the endoplasmic
reticulum (ER) stress-unfolded protein response (UPR) factor IRE1 (termed IRE1, hereafter),
activated by the signals of cytokines IL-23 and IL-6 and those of TCR engagement and
costimulation, contributes to the expansion of ER capacity and autophagy, leading to the
enhancement of secretory function and the restoration of cellular homeostasis in TH17 cells. The
signals of these cytokines and TCR/costimulation converge at STAT3 and IRE1. We thus
hypothesize that targeting both IRE1 and STAT3 pathways may result in TH17 cell death and
therefore, diminish the pathogenic function of these cells. Our preliminary study, demonstrating
that simultaneous inhibition of IRE1 and STAT3 leads to massive TH17 cell death, strongly
supports this. This proposal will initiate to explore the mechanisms of the induction of TH17 cell
apoptosis and study the potential applications of this approach by using preclinical animal models.

Public health relevance
Project Narrative TH17 cells, a type of immune cells, play a notorious pathogenic role in many inflammatory and autoimmune diseases. Currently, there are only limited treatments for TH17-mediated diseases. Besides, activating the death pathways in TH17 cells, which may control the diseases at the root, remains elusive and represents a critical gap in our knowledge. TH17 cells are resistant to activation-induced cell death and steroid treatments. Therefore, we explored non-steroid pathways that control TH17 cell function and survival. Our preliminary study demonstrates that simultaneous inhibition of IRE1 and STAT3 leads to massive TH17 cell death. This proposal will explore the mechanisms of the induction of TH17 cell death and study the potential applications of this approach. This proposal will uncover a previously unacknowledged mechanism controlling the survival of pathogenic TH17 cells. This project holds strong potential for the development of novel therapeutic approaches for human inflammatory and autoimmune diseases.